Matrix-Addressable X-ray Source for Medical Imaging

DESCRIPTION (provided by applicant): We propose to develop a new x-ray source for medical research and diagnostic applications. The development of this source could radically change the use of x-rays in areas ranging from digital tomosynthesis to computed tomography (CT). The proposed source is a high-bandwidth, matrixaddressable array of individual cold-cathode x-ray point sources that can be made to cover areas of roughly one square millimeter to several square meters. This flat panel x-ray source could be used to construct, for example, compact, flat-panel-based tomography systems for use in the field, laboratory, and rural clinic. The objective of the proposed research is to validate the operation of the flat panel x-ray source by demonstrating a functional prototype. The specific aims of this 2-year research program are to: (1) design, build, and characterize a prototype x-ray source and (2) demonstrate source operation with conventional xray radiographs and quantify source performance using standard image assessment techniques. Following the successful completion of this program we will apply for a follow-on grant to continue the refinement and development of the x-ray source. This research will involve more detailed studies of image assessment combined with further quantification of how various source preparation and operating parameters influence the x-ray panel source's output, reproducibility, and lifetime.